HIGH DOSE CYTOXAN IN PATIENTS WITH CHRONIC PROGRESSIVE MULTIPLE SCLEROSIS

Cooperative trial to evaluate high-dose cytoxan administration as a treatment regimen for patients with chronic progressive multiple sclerosis.